Sustainable Software Tools for Neuromodulation Prediction

Project Summary/Abstract
SCIRun, is an open-source problem solving environment that was developed in previous NIH-funded projects
to enable all aspects of bioelectric field simulation, with a special emphasis on applications to neuromodulation
and stimulation of the brain. Many advancements in transcranial (TMS, tCS) and invasive stimulation (DBS,
sEEG, ECoG) have relied on computational simulation and optimization methods and many have used SCIRun
to perform these simulations. However, SCIRun’s capabilities have fallen behind as stimulation methods have
expanded (e.g., more complex stimulation electrodes with different sizes and numbers of electrodes). Moreover,
any software product, especially with the complexity of SCIRun, also requires constant updates to remain com-
patible with emerging operating systems and support libraries. We propose major upgrades and expansions
of SCIRun through technological, infrastructure, interface, and training advancements. These improvements
will make the package more efficient, flexible, and comprehensive. We will strongly broaden its use cases for
scientists by developing new stimulation methods that may improve treatment outcomes and reduce costs for
a range of pathologies. These improvements are also specifically aimed at making SCIRun more accessible to
clinicians who can use our tools for individualized treatment planning and increased patient understanding. Of
special interest will be applications in neuromodulation, a domain with vibrant growth in the exploration of novel
electrode configurations and target interventions. To support these specific innovations will require improve-
ments to the general software environment to reflect contemporary computing resources. Such changes in the
research computing ecosystem provide opportunities for pipeline integration, distribution, and democratization
of computing access. Changes that we wish to leverage include the explosion of Python as a development
environment, which has seen considerable investment in infrastructure, support, capabilities, and distribution
that remain open source and accessible. Similarly, improvements in cloud computing, web applications, and
deployment technology have made these avenues more accessible. In addition to improving capabilities, inter-
operability, and distribution, leveraging these open-source tools and ecosystems will connect us to active user
communities, providing further opportunities for exposure, support, and sustainable benefits.

Public health relevance
Project Narrative The outcome of this project will be a new and dramatically improved simulation environment (SCIRun) that will support novel brain stimulation research and treatment for decades to come. The proposed improvements provide a foundation of sustainable future progress through user and developer contributions, and will enable faster integration of new technologies with Python prototypes and easy inclusion of existing Python libraries. With the improved SCIRun, researchers will be able to use emerging technology in unique and novel ways to advance discovery in brain stimulation therapy.